INVESTIGATIONS OF MACROMOLECULAR STRUCTURES AND DYNAMICS IN SOLUTION BY NMR

The objective of the overall research in this laboratory is centered on achieving as complete a description as possible for the structures of peptides, proteins, nucleic acids and their complexes in solution, principally by NMR spectroscopy. At present particular emphasis is being placed on developing approaches which allow the investigation of larger and complex systems as well as increase the precision with which these solution structures can be obtained. Studies aimed at correlating structure and function, and experiments aimed at investigating protein folding are conducted. Structural studies for several proteins have been carried out. These include the N-terminal domain of HIV-1 integrase, the chemokine SDF-1, and cyanovirin-N. In addition, work was also carried out on a number of protein nucleic acid complexes, including those of the wild-type SRY and a sex-reversal mutant of this protein, Are A and Mef-2. Methodology for the large scale preparation of isotopically labelled DNA for structural studies was refined and optimized. In addition, from the mutant core libraries of streptococcal Protein G an unusual, tertameric variant has been characterized. As one of the largest systems to date, the NMR structure of EI-N complexed to HPr was determined. New media for partially aligning molecules in the magnetic field were developed and exploited for measuring residual dipolar couplings. - NMR structures, DNA binding domains, protein/DNA complexes, protein/protein complexes,isotope labelling of DNA, heteronuclear NMR.